Administrative Core

SUMMARY – ADMINISTRATIVE CORE
The Administrative Core (AC) will provide oversight, coordination, and integration of all activities of the Drexel
Center on Climate Change and Urban Health (CCUH). It will support the organizational structure and
infrastructure needed to advance the central theme of the CCUH: the creation and dissemination/translation of
evidence that will support urban policies to address the health and equity impacts of climate change in cities.
The AC will leverage significant prior experience at the Drexel Urban Health Collaborative in leading and
coordinating large multinational and transdisciplinary research collaborations with a focus on urban health and
health equity in ways that are inclusive and informative for policy, practice and community action. The AC will
establish a Center Executive Committee and convene an External Advisory Board composed of external
experts and leaders who will provide input into the overall direction of the Center. The Administrative Core will
ensure that the activities of the Research Project, the Research Capacity Building Core (RCBC), and the
Community Engagement Core (CEC) are coordinated and synergistic and that our partners (University of
California Berkeley, the University of Sao Paulo in Brazil, and Institute for Nutrition of Central America and
Panama (INCAP) in Guatemala) are meaningfully engaged and supported. The AC will develop and implement
a data infrastructure and management plan that facilitates collaboration and will support synthesis and
communication of key findings to stakeholders in ways that are useful for action. The AC will also monitor and
evaluate all Center activities including our plan to promote and support diversity and inclusion, and coordinate
engagement and collaborations with the Climate Change and Health Research Coordinating Center and the
broader Community of Practice. Finally, the Administrative Core will support the development of an agenda
and priorities for the future, including plans to secure additional funding and expand the research, capacity
building, and policy and community engagement work to a broader network of countries and cities across the
Americas in ways that support solutions-oriented research. The specific aims of the core are: (1) To establish
and sustain a participatory governance and administrative structure that provides programmatic and budgetary
oversight, that ensures coordination and integration of all Center activities, and that regularly monitors,
evaluates and reports on all activities; (2) To ensure that diversity and inclusion are prioritized and integrated
within all Center activities; (3) To develop and implement a data infrastructure plan that facilitates access to
and use of data on the impacts of climate change on health in urban areas for research as well as for
dissemination and engagement purposes. (4) To synthesize and communicate Center findings and lead the
development of a broader research and engagement agenda on climate change and health in urban areas that
engages multiple stakeholders at Drexel University and beyond, establishes programmatic directions and
identified new funding opportunities to ensure sustainability and expansion of Center activities into the future.